Investigating and targeting the translational landscape of DBA

In ribosomopathies, perturbed expression of ribosome components leads to tissue-specific phenotypes, such
as limb and craniofacial defects as well as bone marrow failure. A key example of a ribosomopathy is Diamond
Blackfan Anemia (DBA) which results in an erythroid-specific disease manifestation. What accounts for such
tissue-selective manifestations as a result of mutations in the ribosome, a ubiquitous cellular machine, has
remained a mystery. Our preliminary data strongly support that translational dysfunction may contribute to
disease pathogenesis. In particular, our findings show that translational specificity to gene expression upon
ribosomal protein (RP) haploinsufficiency may arise from an intermediary pathway, the p53-4E-BP1-eIF4E
axis, which becomes activated and links RP haploinsufficiency to selective changes in cap-dependent
translation, namely mRNAs with structured 5’UTRs that require eIF4A helicase activity or that have a specific
sequence element. This preliminary data strongly supports the rationale to examine translational control and
protein synthesis within the hematopoietic compartment, which has been previously unattainable to resolve
and has limited our understanding of DBA pathogenesis. Strikingly, while it has been known for over 20 years
that RP mutations lead to bone marrow failure associated with ribosomopathies, there has not been any
genome-wide studies to pinpoint specific translation impairments underlying hematological abnormalities in-
vivo. This is at least in part due to a technical limitation in being able to employ technologies such as ribosome
profiling analysis for small numbers of cells. In Aim 1, we will utilize a new technology optimized for small cell
numbers to characterize the translational landscape of gene expression for the first time within the early
erythroid lineage of the hematopoietic compartment of a faithful DBA mouse model. This will enable
characterization of the global translation landscape of gene expression underlying hematopoietic dysfunction in
vivo in DBA for the first time. In Aim 2, we will test the hypothesis that the translation factor 4EBP1 play a
causative role in alterations in transcript-specific translational control underlying DBA disease pathogenesis
and address the fundamental question of whether shared structural features are present in the 5’UTRs of
selective mRNAs that account for specificity to gene expression changes underlying ribosomopathies. In Aim
3, we will undertake a state-of-the-art chemical screen to, for the first time, identify translational activators that
have the potential to transform the treatment of DBA. In particular, by leveraging over 130,000 diverse
compounds available at the High Throughput Screening Knowledge Center (HTSKC), the chemical space will
allow for mechanistically novel hits to emerge, including those that directly target the protein synthesis
machinery. Together, this proposal holds the potential to transform our understanding and treatment of an
entire class of human diseases.

Public health relevance
In humans, mutations in a number of core ribosome components lead to ribosomopathies, including Diamond- Blackfan anemia (DBA), which is characterized by fatal bone marrow failure. In all of these cases, the mechanism(s) that would account for cell type specific changes in hematopoietic cells underlying these diseases remain poorly understood. Here, we propose to employ novel technologies to pinpoint how alterations in accurate control of translation causes bone marrow failure in these diseases and identify small molecules that activate translational control as a new targeted therapy for DBA.